ANTIRETROVIRAL MANAGEMENT FOR PEDIATRIC HIV PATIENTS

ACTG 366: The purpose of this study is to determine: 1) if treatment with certain drug combinations will decrease the amount of HIV in the blood and how long this decrease might last; 2) if the drug combinations can be safely given to children and adolescents who have advanced HIV disease or have not benefitted from other treatments for HIV disease; and 3)the right doses of these drugs when these drugs are used in various combinations.